14th International Bordetella Symposium

SUMMARY
Bordetella species are significant agents of morbidity and mortality worldwide, manifesting the life-threatening
disease pertussis in humans and severe respiratory infections in animals. Despite the availability of pertussis
vaccines, in the past 15 years, the World Health Organization has estimated the global impact of pertussis to be
16 to 24 million cases per year, with 160,000 to 195,000 deaths per year in children. Recent reductions in COVID-
19-related restrictions have correlated with increased pertussis incidence. Indeed, in the US, weekly reported
cases of pertussis in 2023 are double those reported in 2022. The first International Bordetella Symposium, held
in Prague, Czechoslovakia in 1962, was an opportune moment for world leaders to discuss outcomes of the
introduction of a whole cell pertussis vaccine and the emergence of an “extracted” acellular vaccine. The 14th
International Bordetella Symposium will be held at the Institute of Microbiology of the Czech Academy of
Sciences, Czech Republic, on June 24-28, 2024. This conference is well-timed to foster dynamic scientific
exchange between scientists, physicians, public health officials and industry representatives and advance the
field by addressing current challenges imposed by suboptimal vaccination approaches, increasing pertussis
incidence and the continued economic burden of Bordetella spp. on agriculture. The location offers an affordable
conference center close to accommodation in a city that is readily accessible to international travelers. Meeting
halls have high-quality technical equipment, supporting the attendance of virtual conferees and onsite skilled
technical assistance. In addition, onsite exhibition, catering, and meeting spaces along with guided tours and
conference dinners will facilitate discussions in a casual atmosphere beyond the program schedule. The
objective of the 14th International Bordetella Symposium is to i) provide high-quality scientific programming and
an opportunity for the global exchange of knowledge and skills; ii) facilitate the career development of early
career researchers in a safe environment; and iii) ensure diverse representation at all levels, from conference
organizers to attendees, and showcase diversity, equity, and inclusivity in the Bordetella field. The conference
will include keynote speakers intermingled with short talks, panel discussions and poster presentations.
Members of the Scientific Organizing Committee and Diversity Ambassadors will select short talk presenters
based on the quality and originality of their research and speaker background as a nationally (US)
underrepresented group or group underrepresented in the Bordetella community. Advertisements on society
websites, social media and mailings will emphasize the availability of travel awards for attendees from
underrepresented groups and first-generation students. Upon registration, those requiring childcare will receive
information on services and access to financial support from the International Bordetella Society. We anticipate
approximately 200 in-person attendees and 100 virtual attendees, with >50% US representation. There is no
equivalent conference providing an international platform for Bordetella discussion.

Public health relevance
Project Narrative Despite the availability of vaccines, diseases caused by Bordetella species continue to have a significant impact on the morbidity and mortality of humans and animals worldwide. There is an imperative need for an improved understanding of Bordetella evolution, diversity, and mechanisms of virulence to guide the informed development of next generation vaccines and therapeutics. The 14th International Bordetella Symposium will provide a forum for scientists, physicians, public health officials, regulators, and industry representatives to collaborate on the shared objective of realizing novel strategies for the control of diseases caused by Bordetella spp. in a diverse, equitable, and inclusive scientific environment.